Cooperative Human Tissue Network

PROJECT SUMMARY / ABSTRACT
The Cooperative Human Tissue Network (CHTN) was established as a mechanism to provide the scientific
community with high-quality human biospecimens for research. The CHTN allows investigators to access the
biospecimens they need to perform cutting-edge research, including basic and early translational cancer
research, and laboratory assay development.
As one of six CHTN Divisions, the Pediatric Division of the CHTN (pCHTN) will receive, process, and distribute
scientifically relevant biospecimens collected from children, adolescents, and young adults. These
biospecimens can include malignant, benign, disease-involved, and uninvolved biospecimens. The pCHTN
seeks to directly promote and support cutting-edge research in the diagnosis, biologic behavior, and treatment
of acute and chronic diseases including cancer by pursuing the following specific aims:
1. To leverage the relationship with the Children’s Oncology Group , in addition to Nationwide Children’s
Hospital Department of Pathology and Laboratory Medicine to procure a wide range of well-annotated
biospecimens from a variety of both cancerous and non-cancerous conditions, including biospecimens
from rare tumor types.
2. To support cutting-edge research by distributing high-quality biospecimens to approved investigators.
3. To maximize limited biospecimen resources and provide economies of scale by performing additional
processing of biospecimens (e.g., nucleic acid extraction, tissue microarray creation, digital images of
stained tissue slides, etc.)
4. To maintain a reliable and robust Quality Management Program that monitors all aspects of
biospecimen collection, processing, storage, and distribution in an effort to continuously evaluate and
improve our operational capabilities, assess best practices, ensure investigator satisfaction, and protect
the privacy and confidentiality of those individuals from whom the biospecimens and data were
obtained.
5. To actively contribute to the CHTN by participation and collaboration in Network interactions,
particularly in fulfilling highly customized or non-standard requests, participating in collaborative
Network activities, and coordinating or developing new strategies to ensure that the CHTN remains
responsive to the needs of the scientific community.

Public health relevance
PROJECT NARRATIVE The Cooperative Human Tissue Network (CHTN) was established to address the increasing demand by the scientific community for access to high-quality human biospecimens for research. The scientific community can request CHTN biospecimens to perform cutting-edge research, including basic and translational cancer research, as well as assay development. The goal of the Pediatric Division of the CHTN is to support pediatric and adolescent research (including cancer) by collecting, processing, and distributing high quality biospecimens to approved investigators.